2020 Enzymes, Coenzymes and Metabolic Pathways Gordon Research Conference and Gordon Research Seminar

Project Summary This proposal seeks partial support for the 2020 Enzymes, Coenzymes, and Metabolic Pathways GRC/GRS. These meetings are scheduled for July 25–26 (GRS) and July 26–31 (GRC) at the Waterville Valley Conference Center, in Waterville Valley, NH. The “Enzymes” GRC/GRS is the paramount conference for scientists investigating the structure and function of enzymes and their role in metabolism and disease. The long-term goals of this conference are to stimulate communication within the broad research community with interests in the roles of enzymes in life's essential biological processes. To reach these goals, the GRC has developed a technical program of 36 speakers (27 invited and 8 selected from poster abstracts), and the GRS has assembled a program of 9 speakers (1 invited and 8 chosen from poster abstracts) as well as a Bioscience Careers Panel consisting of ~5 leaders from various backgrounds. These oral presentations will disclose the most recent findings in enzymology, experimental method development, as well as how these are implicated in disease. Afternoon poster sessions provide an opportunity for all attendees to share their discoveries with the broader scientific community. Of particular importance is that these poster sessions encourage close interactions among both junior and senior investigators. This proposal has high significance because the “Enzymes” GRC is a pivotal conference for researchers investigating the mechanisms of biochemical reactions and provides a central venue for the exchange of knowledge in this essential health-related field. From a healthcare perspective, this proposal is highly significant due to its focus on the development of new enzyme-targeted drugs. A major outcome of this proposal will be the continued elucidation of how enzymes, co-enzymes, and metabolic pathways contribute to the development of new pharmaceuticals, especially for the treatment of infectious diseases and cancer.

Public health relevance
Project Narrative Enzymes and coenzymes govern nearly all metabolic reactions in nature. Because of this, our understanding of how enzymes function has a major influence on our ability to ameliorate disease. A significant challenge facing enzymologists is the elucidation of the mechanisms of enzymatic reactions and the determination of how enzymes function in cellular contexts. Addressing these issues and developing strategies for intervention that promise to improve healthcare are central topics of this conference.